CCSG Supplement: To Strengthen the Research, Training, and Outreach Capacity

Abstract
The Fred Hutchinson/University of Washington/Seattle Children’s Cancer Consortium is deeply
committed to increasing the diversity of the cancer research workforce. Central to our efforts is
enhancing our existing partnerships with Minority-Serving Institutions (MSIs), as well as
developing new partnerships. Summer undergraduate training programs currently exist between
our cancer center and Morehouse College (a HBCU), Spelman College (a HBCU), and New
Mexico State University (a Hispanic-Serving Institution). Additionally, we have experience
identifying and supporting the career development of scholars and early-stage investigators
throughout the west coast through our 10+ year history leading our region’s NCI-funded Center
to Reduce Cancer Disparities (CRCHD) Geographic Management of Cancer Health Disparities
Program (GMaP). In particular, our current 2-year GMaP cycle directly engaged with 83
potential CURE scholars and supported them by providing annual career development
workshops, expert grant reviews, research stimulus awards, and conference travel awards.
Thus, we are ideally positioned to execute this supplement and achieve each of the following
specific aims:
Aim 1: Identify URM trainees and ESIs through our cancer center’s Minority Serving Institution
(MSI) partners and engage them in the NCI/NIH-supported scholar pathway programs
with an emphasis on those interested in cancer health disparities research.
Aim 2: Provide robust and comprehensive support for the career development of URM trainees
and ESIs by providing career development workshops tailored to their specific needs,
1:1 support for grant writing through leveraging our team of Training Navigators (TNs),
and awarding travel scholarships.
Aim 3: Track and monitor the progress and productivity of newly identified URM scholars and
develop tailored strategies to support each of their longer-term career development
plans.
A critical element of our program is our cadre of 8 Training Navigators who are faculty at our
cancer center and all of whom themselves are underrepresented racial and ethnic minorities
based on the NIH definition. Our aims will be completed through partnering with a total of 8
MSIs including five that we have existing collaborative programs/relationships with (Morehouse
College, New Mexico State University, Spelman College, the University of California, Irvine, and
the University of Guam) and three that are new partnerships (Clark Atlanta University, Diné
College, and Stillman College). Of note, these institutions include a mix of four HBCUs, two
Hispanic-Serving Institutions, one Tribal College, and two Pacific Islander-Serving Institutions.

Public health relevance
Narrative This supplement supports enhanced partnerships between the Fred Hutchinson/University of Washington/Seattle Children’s Cancer Consortium and Minority-Serving Institutions in order to diversify the cancer research workforce and expand capacity to conduct cancer disparities research.